Co(II) Radical Pair Dynamics in B12 Enzyme Catalysis

Project Summary
The goal of the proposed research is to elucidate fundamental physical-chemical
principles that govern catalysis in enzymes, with a focus on radical catalysis in
coenzyme B12 (adenosylcobalamin) –dependent enzymes. This goal will be
enacted through a program of biochemical and physical studies of
representatives of all three classes of B12 enzymes: methylmalonyl-CoA mutase
(MCM, Class I; human and Methylobacter extorquens), ethanolamine ammonia-
lyase (EAL, Class II; Salmonella typhimurium), and lysine-5,6-aminomutase
(Class III; LAM, Clostridium stricklandii). The approaches will be extended to
address molecular mechanism in the intracellular cobalamin (B12) trafficking
pathway in humans by the CblC and CblD proteins, and to the assembly and
function of the bacterial microcompartment (BMC), an in vivo context of the EAL
enzyme. Innovative methods, sofware and hardware for high-resolution pulsed-
electron paramagnetic resonance (EPR) spectroscopy, in parallel with time-
resolved, single-step reaction kinetics and steady-state solvent dynamics from
continuous-wave EPR methods, applied in unique, low-temperature systems, will
enable comprehensive characterization of the structural and dynamical
contributions of solvent-protein-reaction coupling to radical rearrangement
catalysis in the B12 enzymes. Significant biomedical and human health outcomes
include: (i) fundamental knowledge about the role of protein and coupled solvent
configurational states in enzyme function, latent at physiological temperatures,
that contribute new tools, models and targets to the developing roadmap for
leveraging these states in drug development and enzyme engineering, (ii)
characterization of EAL, a contributor to the role of the gut microbiome in human
health and disease progression, including links with inflammatory bowel disease,
obesity, and diabetes, (iii) characterization of the assembly and function of the
ethanolamine utilization (eut) BMC, one of a recently-recognized, widespread
class of primitive, protein-encased bacterial organelles, (iv) insights into the
molecular mechanistic basis of human metabolic disorders identified with the cbl
gene cluster, and in particular, the role of the human CblC (MMACHC,
methylmalonic aciduria type C and homocystinuria) and CblD proteins.

Public health relevance
Project Narrative The goal of the proposed research is to elucidate fundamental physical-chemical principles that govern catalysis in enzymes, with a focus on radical catalysis in B12-dependent enzymes. Biochemical and physical studies of representatives of all three classes of B12–dependent enzymes, intracellular cobalamin trafficking and delivery proteins, and the ethanolamine-utilization bacterial microcompartment, enabled by innovations in EPR spectroscopic methods, sofware and hardware, will reveal how solvent-coupled protein configurational dynamics and resolved protein configurational states guide enzyme function. Significant biomedical and human health outcomes include new tools and models for drug development and enzyme engineering, characterization of an enzyme and primitive bacterial organelle that contribute to the role of the gut microbiome in human health and disease progression, and insight into the molecular mechanistic basis of human disorders of B12 assimilation, including methylmalonic aciduria and homocystinuria.